Cancer Center Support Grant: Geographical Management of Cancer Health Disparities Program (GMaP)

Abstract People of color and rural populations in the American South continue to experience disproportionately high cancer morbidity and mortality, despite decades of efforts to reduce such disparities. Critical to identifying and addressing the complex biological, social, structural, psychological, and clinical determinants of cancer disparities is multidisciplinary research that can leverage existing resources, facilitate cross-disciplinary scientific linkages, and translate evidence into effective interventions and programs that can be implemented in the real world. In addition, ongoing tracking and development of biospecimen resources and mentoring networks are needed to enable efficient resource-sharing and identification of opportunities for new scholars— in particular, from groups that are under-represented in the biomedical sciences, whose diverse expertise and lived experiences are crucial to moving the needle on cancer outcome disparities. NCI-designated cancer centers play an essential role in identifying the determinants of disparate cancer outcomes, developing multicomponent strategies to address these determinants, and supporting the development and sustainment of biospecimen repositories and other resources across translational basic, clinical, and population science. The Lineberger Comprehensive Cancer Center (LCCC) at the University of North Carolina at Chapel Hill has leveraged existing partnerships and collaborations with other cancer centers, minority serving institutions, and communities across North Carolina, South Carolina and Tennessee to serve as Regional Coordinating Center for GMaP Region 1 South for the past two years. Region 1 South has thrived in the establishment of networking and information sharing opportunities through its regional webinars and email newsletters, identification and support of Continuing Umbrella of Research Experiences (CURE) scholars, and leadership in connecting under-represented scholars to existing data resources and mentors throughout the network. In this application, we propose renewing our existing leadership structure, including continued engagement of our exceptional Steering Committee, to continue to support cancer health disparities research, to extend and sustain our ongoing biospecimen repositories, to continue to train, mentor, and connect under-represented scholars to each other and to existing resources and funding opportunities, and to develop a sustainability plan to maintain Region 1 South infrastructure for disparities research, outreach and education beyond the award.

Public health relevance
Project Narrative NCI-designated cancer centers play an essential role in identifying determinants of cancer disparities in medically underserved populations, developing interventions and implementation strategies to address these disparities, promoting the education and mentoring of cancer disparities scholars, and supporting the development and sustainment of biospecimen repositories and other resources across translational basic, clinical, and population science to enhance disparities-focused research. The NCI-designated Lineberger Comprehensive Cancer Center (LCCC) at the University of North Carolina at Chapel Hill has demonstrated a strong commitment to cancer disparities research and the development of scholars underrepresented in the larger cancer research community with outstanding expertise, research infrastructure, mentoring networks, bio- repository resources, and reach into community and clinical settings. With a steering committee representative of Region1-South, we propose continuing the implementation of the Geographic Management of Cancer Health Disparities Program (GMaP) efforts to enhance cancer disparities research and workforce capacity and to develop plans to sustain them.